Targeting Macrophage Populations to Attenuate Pulmonary Hypertension Associated with Sickle Cell Disease

Project Summary: Sickle Cell Disease (SCD) is a genetic mutation that leads to hemoglobin (Hb)
polymerization within the red blood cell (RBC), causing the characteristic sickle shape and
subsequent hemolysis. Approximately 5-10% of the SCD population suffers from pulmonary
hypertension compared to 1 in 3 million in the general population. The 5-year survival rate of SCD
patients with PH is ~32%, higher than SCD patients without PH (~16%). A leading hypothesis for
why the SCD patient population has such a greater prevalence of PH is that iron toxicity caused
from hemoglobin or heme released during RBC hemolysis drives vascular lung injury and
inflammation as observed by iron accumulation within the lungs of PH SCD patients. Iron
accumulation stimulates an inflammatory cascaded leading to chronic inflammatory conditions
within the lung microenvironment. Within chronic inflammatory diseases, such as PH and SCD, a
disorganized area of adaptive and innate immune cells amasses in the lung as tertiary lymphoid
structures. A critical cell type for adaptive immune cell (B and T cells) activation is the CD169+
macrophage found within the tertiary structure. Classically, these macrophages surround B and
T cell areas within the spleen and lymph nodes, providing crucial support and cross talk for
adaptive immune system activation. Thus, our overall hypothesize of this proposal is CD169+
macrophages are critical for PH disease progression in SCD. This hypothesis will be tested
in three aims. Aim 1 will determine if targeting iron release from the ferroportin transporter modify
CD169+ macrophage and adaptive immune cell quantities, phenotypes by multi-omics analysis,
and oxidative status. Aim 2 will determine if ablation of CD169+ inhibits PH disease progression
by altering the quantity and phenotype of adaptive immune cells within the lung, as determined
by flow cytometry, multi-omics approach, and electron paramagnetic resonance. Aim 3 will
determine if CD169+ macrophages are critical for adaptive immune cell recruitment to the lung
microenvironment. Together, these aims will emphasize the importance of a specific cell type and
allow for future projects and therapeutic targets with SCD PH. Receiving this award would
drastically improve my career path towards independent research at the University of Colorado
Anschutz Medical Campus.

Public health relevance
Many complications arise from Sickle Cell Disease, which effects a disproportionate amount of under representative population. My studies further our understanding of how one complication (chronic lung disease) progresses in these patients.